Role of Atp6ap2 in renal proximal tubule lipotoxicity

Project Summary
The rising rates of obesity worldwide contribute directly to an increased prevalence of chronic kidney
disease. With current methods for mitigating obesity related kidney injury incompletely effective, novel
approaches to this problem are needed. In renal lipotoxicity, toxic lipid metabolites accumulate in certain
kidney cell types, including proximal tubule cells. This has recently been identified as an important mechanism
behind obesity related kidney disease but is also not well understood.
In obesity, greater proximal tubule uptake of lipid occurs through increased luminal endocytosis of fatty
acid bound to albumin, facilitated by interaction of the vacuolar H+ -ATPase and mTOR with the
megalin/cubulin complex. At the same time, decreased activation of renal AMPK in obesity leads to decreased
fatty acid oxidation through inactivation of PGC-1α, and CPT1A, further resulting in intracellular lipid
accumulation in the proximal tubule. ATP6AP2 is an integral component of the vacuolar H+ -ATPase and has
also been shown to have a role in intracellular energy signaling including inhibition of AMPK and PGC-1α as
well as activation of mTOR in diabetes. Renal cortical ATP6AP2 expression increases in obesity but its role in
lipotoxicity is unknown. Mice with nephron specific ATP6AP2 knockout during obesity have increased urinary
excretion of albumin and fatty acid, reduced proximal tubule lipid content during diet induced obesity,
decreased endoplasmic reticulum stress, a marker of lipotoxicity, and altered intrarenal lipid profile. This
proposal will test the hypothesis that in obesity ATP6AP2 promotes proximal tubule lipotoxicity through
endocytosis of albumin bound fatty acid as well as reduced intracellular fatty acid oxidation. Aim 1 proposes
that ATP6AP2 increases fatty acid endocytosis through the H+ -ATPase/mTOR/megalin/cubulin. Aim 2 will
test the hypothesis that ATP6AP2 reduces fatty acid oxidation through AMPK/PGC-1α/CPT1A..
This project will also greatly facilitate my career development toward the goal of becoming a fully
independent physician scientist performing basic and translational research. The career development plan
described in this application will include formal training in lipid science and lipidomics, the use of transgenic
mouse models, microscopy, and scientific writing, as well as mentorship by leaders in endocrinology and lipid
science including my mentors Drs. Helmy Siragy and Thurl Harris. This will take place at the University of
Virginia, an excellent research training environment with state-of-the art research facilities and core
laboratories as well as a superb academic environment for early career scientists. Data generated by the
proposed studies will establish the basis for an independent research career, distinct from my mentors.

Public health relevance
Project Narrative Obesity is an independent risk factor for the development of chronic kidney disease, but current strategies for the prevention and treatment of obesity related kidney injury are incompletely effective. Lipotoxicity is a recently identified process that contributes to kidney injury in the setting of obesity, but the mechanisms underlying lipotoxicity in the kidney are not fully understood. This studies in this proposal will investigate the role of ATP6AP2 in promoting renal lipotoxicity with the goal of providing a basis for novel therapeutic strategies in the management of obesity related kidney disease.